ACORN: BioCore

The primary function of the Biospecimen Core (BioCore) is to provide investigators of the Alcohol Center of
Research-Nebraska (ACORN) key support for the novel alcohol exposome projects and their significant
contributions to the field. The BioCore will provide expert assistance for the design of translational models and
a centralized mechanism for animal and human sample accrual. The BioCore will ensure standardization of
sample preparation and integrity; uniformity of protocols and procedures; and data collection, reporting and
sharing. At a minimum, the well-governed and supported BioCore will bank and distribute animal and human
samples for all four of the ACORN projects. Additionally, project milestones and deliverables will be
significantly supported through a searchable online inventory, annotated sample characteristics, and the
coordination and dissemination of available resources and collaborative support. Further, the BioCore will
facilitate educational seminars, training, and collaborative opportunities with local and national resources to aid
in the success of the alcohol exposome projects and future strategies.